Neuronal and behavioral effects of an implicit priming approach to improve eating behaviors in obesity: Diversity supplement.

PROJECT SUMMARY/ABSTRACT
Weight loss is associated with a reduction in obesity-related health risks, but can be difficult, with preventing
subsequent weight regain even more challenging. As such, understanding mechanisms underlying energy
balance regulation and identifying strategies for successful weight loss and maintenance are important goals,
and are key components of the Strategic Plan for NIH Obesity Research. One factor that may contribute to
susceptibility to obesity is a high responsivity to high-calorie foods, which promotes increased caloric intake.
The parent study for this supplement aims to investigate the neuronal and behavioral effects of an intervention
designed to alter affective associations with food, using a novel implicit priming paradigm. Parent project goals
are to further delineate the neuronal mechanisms underlying the intervention, establish intervention impact on
longer-term food preferences and eating behaviors, and determine if it can facilitate weight-maintenance in
individuals with overweight/obesity. Effects of the intervention on neuronal responses to visual food cues and
measures of eating behaviors (food intake, preferences) are measured acutely, but also following 12 weeks of
weekly intervention. Weight and body composition are measured before and after the intervention, and, to
assess lasting effects, 12 weeks after the intervention has ended. This supplement to promote diversity in
health-related research will support research training and career development for an incoming graduate
student who belongs to a group underrepresented in health-related research. The supplement will support her
addition of an assessment of early-life adversity to the parent project, to determine if early-life adversity
impacts the neuronal response to food cues in brain regions involved in reward processing, and if this
mediates effects of adversity on adiposity. The supplement project fits well within the scope of the parent grant,
will strongly support the PhD candidate’s research and training goals, and will also meaningfully contribute to
the parent project.

Public health relevance
PROJECT NARRATIVE The overall goals of the parent project are to determine the impact of an implicit priming intervention, designed to alter food perceptions, on brain responses to food, food intake behaviors and weight-loss maintenance in individuals with overweight/obesity. The proposed supplement will add an assessment of early-life adversity to the parent project, to determine if early-life adversity impacts the neuronal response to food cues in brain regions involved in reward processing, and if this mediates effects of adversity on adiposity. This project will support research training for an incoming graduate student from a group underrepresented in health sciences.